DOUBLE-BLIND RANDOMIZED STUDY OF IV LIPO-PGE-1 THERAPY IN ISCHEMIC ULCERS

The purpose of this phase III, multicenter study is to evaluate the safety and efficacy of intravenous bolus infusion of Lipo-PGE1 in two dose levels of 20 & 80 micrograms (mcg) in patients with atherosclerotic peripheral arterial occlusive disease and ischemic ulcers. The major endpoints for efficacy will be the rate of ulcer healing, relief of pain and decreased limb amputation.